Core A

PROJECT SUMMARY
Acute myeloid leukemia (AML) is the most common form of acute leukemia and is increasing in incidence. While
biological insight into the molecular pathogenesis of AML has greatly advanced, the 5-year survival rate has
remained low despite newer FDA-approved therapeutic strategies. This is largely attributed to the heterogeneous
nature of AML with a variety of subtypes defined by clinical, morphologic, cytogenetic, and molecular
characteristics. Consequently, there is a need to develop more effective, molecularly targeted therapies.
Changes in the metabolome are the ultimate “response” to a genetic modification, drug response, or disease
process. Sphingolipids comprise a portion of the metabolome. Consequently, changes in the metabolome,
including sphingolipids, can be more predictive of phenotype than other markers. The premise of our proposal
is based on our published and unpublished studies that revealed perturbations of sphingolipid metabolism,
sphingolipids as biomarkers, and the efficacy of sphingolipid-based therapeutics for AML. The goals of this
Program Project are to extend these studies and further develop improved sphingolipid-based therapeutics.
Towards this end, the Sphingomics & Therapeutics Optimization Core (Core A) serves as a scientific and
methodological connection between the Projects and Cores to analyze changes in sphingolipid metabolism
through mass spectrometry-based analyses of cell line, preclinical, and patient samples. Furthermore, Core A
will provide ADME/PK analyses to ascertain properties of sphingolipid-based therapeutics and optimize drug
delivery strategies for the projects to facilitate drug development. These studies will expedite the design of safer
and more effective strategies to address the current clinical need for improved therapeutics.

Public health relevance
PROJECT NARRATIVE Acute myelogenous leukemia (AML) remains a significant unmet medical need due to the lack of durable treatment options. The Sphingomics and Therapeutic Optimization Core (Core A) will play a pivotal role in understanding alterations in (glyco)sphingolipid metabolism in AML cells. By providing cutting-edge mass spectrometry and drug delivery strategies, we aim to accelerate the development of innovative sphingolipid- based therapies for AML patients.